Statistical Methods for Population Genomics and "Next-gen" Sequencing Data

DESCRIPTION (provided by applicant): Massively-parallel ("next-generation") shotgun DNA sequencing projects will provide the highest resolution to date for genetic variation of human populations. This new technology offers great promise for interrogating the genetic etiology of complex disease. However, with this promise come challenges. These new sequencing methods are prone to nontrivial error rates and sparse coverage of mapped reads, confounding polymorphism discovery and genotyping. Copy number variation must often be inferred indirectly. The massive size of these data sets requires rapid and scaleable analytic approaches. In this proposal, we present statistical methods to address these challenges directly, using computationally tractable models for population genetic variation. Our methods take account of the dependence among nearby alleles (linkage disequilibrium) with a clusterbased model for haplotype variation, and utilize this information to aid inferences about the underlying genetic architecture of the samples. Specifically, we propose to call genotypes and detect novel polymorphic loci from next- generation shotgun sequence data, detect rare disease risk alleles for follow-up sequencing studies, and simultaneously model single nucleotide and copy number polymorphism in population data to facilitate studies of association between phenotype and genotype. Our experienced team of medical and statistical geneticists have the technical expertise and access to data sets necessary for achieving these aims. We will implement our methods in our widely-used software package fastPHASE. PUBLIC HEALTH RELEVANCE: High throughput DNA sequencing technology is providing unparalleled detail of human genetic variation. This will allow finer resolution in locating disease genes that affect human health and disease. Both the large quantity and the uneven quality of this new technology demand new statistical methods for inference, risk assessment and eventually clinical translation.

Public health relevance
High throughput DNA sequencing technology is providing unparalleled detail of human genetic variation. This will allow finer resolution in locating disease genes that affect human health and disease. Both the large quantity and the uneven quality of this new technology demand new statistical methods for inference, risk assessment and eventually clinical translation.